SIREN CORE-EM HUB ALLIANCE

The CORE-EM Alliance (COalition for REsearch in Emergency Medicine) brings to SIREN six, highly experienced research infrastructures, each with their own spokes, partnering as an innovative, single, super-hub within the SIREN network. The goal of CORE-EM is to provide rapid implementation and high-quality performance in large pragmatic clinical trials to study acute conditions including neurologic, cardiovascular, respiratory, hematologic, infectious disease, and trauma-related emergencies. CORE-EM was funded as a SIREN Hub in 2017 to facilitate excellence in resuscitation research. Supporting a >70-million-person catchment area across the US, CORE-EM prioritizes access to clinical trials for individuals across the US. CORE-EM is ranked #2 for enrollments within SIREN.
CORE-EM’s MPI leadership has successfully collaborated for 15+ years to execute clinical trials. MPIs serve on SIREN Governance committees and represent acute care research nationally within the Society for Academic Emergency Medicine, American College of Emergency Physicians, Society for Critical Care Medicine, and through service on NINDS, NCATS, and AHRQ National Advisory Councils. CORE-EM MPIs have assisted in authoring SIREN clinical trials and are actively developing new proposals, such as to study eCPR/ECMO in the Emergency Department (ED), ECPR INSIGHT.
CORE-EM has successfully deployed trials in cardiology, neurosurgery, infectious disease, hematology, and intensive care. This includes implementing the first two EFIC trials in the states of Rhode Island and Florida. Co-investigators engage across specialties to ensure excellence in care from scene of injury, through the ED, operating rooms, ICUs, and into rehabilitation.
Residents and junior faculty are mentored in the CORE-EM Alliance, as co-investigators and site-PIs. CORE-EM is committed to conducting rigorous trials, training the next generation of physician scientists, and providing outstanding clinical care through excellence in research, discovery, and implementation science.

Public health relevance
The CORE-EM Hub Alliance provides rapid implementation and high-quality performance in large pragmatic clinical trials of novel therapeutics for acute conditions, such as: neurologic, cardiovascular, respiratory, hematologic, infectious disease, and trauma related emergencies. CORE-EM is committed to conducting rigorous clinical trials, training the next generation of physician scientists, and improving public health by providing outstanding clinical care through excellence in research, discovery, and implementation science.